Optimizing Gene Therapy for Respiratory Insufficiency in Duchenne Muscular Dystrophy

PROJECT SUMMARY/ABSTRACT
Duchenne muscular dystrophy (DMD) is a devastating X-linked disease with no current cure. DMD is
caused by mutations in the gene encoding dystrophin. Dystrophin is a protein necessary for the maintenance of
muscle structure and is essential for skeletal and cardiac muscle integrity. As muscle damage progresses, the
respiratory muscles become weak and fibrotic leading to hypoventilation and respiratory insufficiency. Sadly,
most patients die from respiratory failure. Further, 1/3 of DMD patients also have neurological manifestations
and central nervous system (CNS) pathology. However, the impact of the CNS pathology in the respiratory-
related morbidity in DMD is unknown. Defining the respiratory muscle and neuropathology is essential as novel
gene therapies using AAV-microdystrophin (AAV-µDys) for DMD enter clinical trials and become FDA-approved.
Several pre-clinical trials with AAV-μDys reveal promising results with dystrophin production resulting in
improved survival and ambulation; however, in these studies the diaphragm was not adequately transduced, and
respiratory outcome was not assessed. Thus, there remains a critical need for a therapy that will halt or reverse
respiratory disease. In our first aim, we will comprehensively examine breathing and the respiratory motor units
in novel humanized mouse models and compare these to the established mdx DMD mouse model. We will then
utilize these DMD mouse models to elucidate the impact of dystrophin deficiency on respiratory neuro-pathology.
Finally, we will examine the efficacy of a novel AAV capsid carrying μDys in treating respiratory pathology and
neuro-pathology in the DMD mouse models. The fundamental hypothesis driving this proposal is that
dystrophin deficiency in both the respiratory muscles and CNS leads to breathing impairments, and
AAV-μDys will correct both the respiratory myopathy and neuropathology. In Aim 1 we will identify the
impact of dystrophin deficiency on respiratory function and histopathology in the humanized mouse models of
DMD. In Aim 2, we will perform physiological, histological, transcriptional, and molecular studies to define the
impact of dystrophin loss on the respiratory centers and motor neurons of the medulla and cervical spinal cord.
Then, we will examine the ability of a novel AAVcc47-µDys to effectively transduce and correct respiratory
muscle and neuro-pathology (Aim 3). The proposed experiments are innovative because the impact of
dystrophin deficiency on breathing and neuropathology in humanized mouse models has not been previously
examined. Defining this pathology will provide clinically relevant outcome measures for future therapeutic
studies. Finally, the use of the novel AAVcc47 to deliver µDys and target respiratory pathophysiology and
neuropathology will provide a much needed therapeutic option for respiratory insufficiency in DMD. Since AAV-
µDys gene therapy is already in clinical trials, this work has the strong potential to quickly translate to clinic and
inform and impact the clinical treatment of boys and young men with DMD.

Public health relevance
PROJECT NARRATIVE Duchenne muscular dystrophy (DMD) is a devastating genetic disease which causes progressive muscle weakness, cardiac and breathing difficulties. There is no cure for DMD, and many patients eventually die from respiratory failure. Furthermore, approximately 1/3 of patients have neurological pathology. In this proposal, we will examine the impact of DMD on the breathing muscles, nerves, and central nervous system in mouse models of DMD that have the human genetic mutation. Next, we will examine the impact of a novel adeno-associated viral (AAV) gene therapy to treat both the breathing deficits and the global pathology of DMD.